Targeting the Epigenetic and Metabolic Control of EBV-Epithelial Cancers

OVERALL – PROJECT SUMMARY
The overall aim of this new Program Project (P01) proposal is to generate highly collaborative and integrated
basic and translational research on the urgent, unmet medical need of epithelial cancers caused by Epstein-Barr
Virus (EBV). EBV latent infection is causally linked to over 200,000 new cancer cases per year. EBV epithelial
cancers represent over 75% of all EBV cancers with highest mortality rates and treatment failures. EBV-
associated gastric carcinoma (EBVaGC) and nasopharyngeal carcinoma (NPC) have many similarities with
respect to viral latency and oncogenic transformation. The mechanisms through which EBV contributes to these
epithelial cancers remains elusive, and to date, there are no viral-specific therapies that are FDA approved to
treat cancers infected with EBV. We have assembled a team of EBV investigators with expertise in
complementary aspects of tumor virology and cancer biology, with specific areas of interest in viral genetics,
epigenetics, metabolism, drug discovery, and models of EBV carcinogenesis. The Program team will collaborate
in a coordinated strategy to identify key viral and cellular vulnerabilities in EBV epithelial cancers that can be
targeted for therapeutic intervention. The Program will test the central hypothesis that EBV cancers arise in the
context of somatic mutations in metabolic and epigenetic pathways that alter EBV latency and oncogenicity, and
how this viral-host co-dependency provides therapeutic opportunities. To achieve these goals for the Program
we propose three Projects and three scientific Cores to address the following: (1) Determine how EBV
establishes a latent and oncogenic infection in epithelial cancer cells (2) Determine how EBV latent
infection drives epigenetic and metabolic shifts including the formation of CpG island methylator
phenotype (CIMP) to promote epithelial cell oncogenesis. (3) Leverage mechanistic insights to develop
new therapeutic strategies to treat EBV epithelial cancers. The 3 Projects focus broadly on EBV latency
and epigenome (Lieberman), PARP, NAD and DNA damage metabolism (Tempera), and DNA methylation and
methionine metabolism (Gewurz). The 3 scientific Cores support bioinformatics, drug discovery, and models of
EBV cancers to support each of the 3 Projects as research enhancers. Together, this team and Program will
investigate key features of EBV cancer mechanisms, build new tools to study EBV cancers, and develop new
therapeutic strategies that are viral-specific and precision-based medicine.

Public health relevance
OVERALL - PROJECT NARRATIVE This is a new program project that brings together experts in Epstein-Barr Virus latency, epigenetics, metabolism, and carcinogenesis with core expertise in medicinal chemistry, drug discovery, bioinformatics, and animal models of EBV cancer. The overall goal is to address the unmet medical need associated with EBV epithelial cancers that exceed 180,000 new cancer cases per year and receive generic, non-viral cancer treatments and have high rates of failure, relapse and resistance. The Program brings together multiple institutions and collaborators to elucidate the basic mechanisms of viral latency and oncogenesis in EBV epithelial cancers, and to identify vulnerabilities and strategies for development of new viral-specific therapies to treat EBV epithelial cancers.